The role of polo-like kinase in the duplication of the trypanosome cytoskeleton

? DESCRIPTION (provided by applicant): Trypanosoma brucei is the causative agent of African trypanosomiasis in humans and nagana in cattle. The few effective treatments available for treating trypanosomiasis are very difficult to administer and resistance is an emerging problem. Few new drugs are under investigation, which makes identifying novel treatments for this pathogen an urgent need. Trypanosomes are highly polarized and have a complex cytoskeleton that positions the parasite's single flagellum in the posterior of the cell and adheres it to the cll surface. This arrangement is necessary for proper motility and completion of cell division. Adhering and positioning the flagellum are essential features of the trypanosome cell cycle that are not conserved in mammals, making these processes attractive candidates for drug intervention. We have identified the polo-like kinase homolog in T. brucei, termed TbPLK, as an essential regulator of the inheritance of a series of cytoskeletal organelles that are essential fo positioning and adhering the flagellum. Inhibiting or depleting TbPLK leads to cells with detached flagella that cannot undergo productive cell divisions. These severe and irreversible defects make TbPLK an attractive drug target and suggest that the kinase may be an important regulator of morphogenesis in trypanosomes. Identifying substrates and binding partners is an essential next step to understanding TbPLK function. These novel proteins could themselves be viable drug targets. We conducted three different proteomic screens to identify novel TbPLK interactors and substrates, which yielded 74 candidates. The work in this proposal focuses on the characterizing the function of these proteins and determining how and when they interact with TbPLK during the course of the cell cycle. Our goal is to use these newly identified proteins to establish the molecular basis for TbPLK control of morphogenesis in T. brucei.

Public health relevance
PUBLIC HEALTH RELEVANCE: Trypanosoma brucei is a devastating pathogen that causes African trypanosomiasis (sleeping sickness) in humans; very few viable treatment options are available, which makes it essential to identify new targets for drug discovery. This project studies a key kinase called TbPLK, which regulates the duplication and inheritance of the trypanosome cytoskeleton. Understanding how TbPLK functions will further establish the kinase as a viable drug target and will uncover other essential components of the trypanosome cytoskeleton, which may also be targets.